Photoreceptor Function in ROP

PROJECT SUMMARY/ABSTRACT
This is a request for one year's supplemental funding, to perform the retinal threshold measurements that were the
centerpiece of Aim 4 of the parent grant, EY-10597-25, “Photoreceptor Function in ROP.” COVID completely shut
down the study, and no participants came into the lab for testing. This included the often-fragile infants and children
with a history of preterm birth, who are the subject of Aim 4. These infants and children have a history of severe
ROP, designated Type 1. In early infancy their retinas had been treated with either laser or intravitreal injection of
bevacizumab (IVB). We propose to recruit from a pool of 111 clinically well characterized Type 1 ROP patients,
half of them treated using laser, the others treated using IVB. We will measure their dark-adapted visual thresholds
at 10° and 30° eccentricities using our previously validated psychophysical procedure. Our overall goal is to learn
more about the development of retinal function in Type 1 ROP, particularly the relationship of retinal function to
refractive development. Early high myopia is a recognized complication of Type 1 ROP, especially following laser
treatment; myopia is less frequent and less severe in those treated using IVB. Our preliminary data, presented in
the application, led us to these testable hypotheses: (1) The near central threshold, 10° eccentric, will be
significantly elevated in the laser treated but not the IVB treated; comparisons will be made to thresholds in healthy,
term-born controls. (2) The more eccentric threshold, 30° eccentric, is significantly associated with spherical
equivalent. We will use linear mixed-effects modeling to evaluate these hypotheses. Factors in the analyses will
be group (laser vs. IVB), age at threshold test, as well as patients' clinical characteristics, including spherical
equivalent and acuity. This supplemental effort will nicely complement the retrospective analyses of refractive and
acuity development that we were able to complete using data gathered pre-COVID.

Public health relevance
PROJECT NARRATIVE Retinopathy of prematurity (ROP) is a leading cause of visual impairment in children worldwide; many ROP patients are at risk for life-long poor vision. We use tests of retinal function and structure to identify mechanisms that control the visual development in patients with a history of preterm birth, with and without ROP. Our research will generate new insights about vision and refractive development that will lead to improved management and treatment of these patients.